ENZYME DIGESTION AND SAX-HPLC OF 3 SAMPLES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Heparinase digestion A 20 [unreadable]L aliquot of a 20 g/L solution of low molecular weight heparin (AVT and HSP) in water was diluted with 80 [unreadable]L 100 mM NaOAc buffer, pH 7, containing 2 mM calcium acetate and 1 g/L BSA. The mixture was then treated with 20 [unreadable]L of a mixture of heparinases I, II, and III (0.5 U/mL each) in 10 mM potassium phosphate buffer, pH 7, containing 2 g/L BSA and incubated at 23 [unreadable]C for 48 h. Reduction A 60 [unreadable]L portion of the heparinase-digested sample was treated with 20 [unreadable]L of a 30 g/L solution of NaBH4 in H2O for at least 24 h at 23 [unreadable]C. SAX-HPLC SAX-HPLC was carried out on an Agilent system using a 4.6[unreadable]250 mm Waters Spherisorb analytical column with 5[unreadable]m particle size at 45 [unreadable]C. Analytes were detected by their UV absorbance at 232 nm using the following system. Solvent A: 2.5 mM Na-phosphate, pH 3.5;Solvent B: 2.5 mM Na-phosphate, pH 3.5, 1.2 M NaCl. After 5 min at 97 % A, a linear gradient was applied to reach 75 % B after 50 min. The flow rate was 1.4 mL/min.